Mechanistic Investigation of RNA-Mediated Gene Regulation and Immunity

Project Summary
The proposed research combines biophysics, molecular genetics, and genomics tools to provide high-
resolution mechanisms for RNA-dominated biological processes. Our study focuses on two central themes in
RNA biology. (1) RNA can serve as an information carrier to guide the action of proteins. Such systems are
inherently precise and programmable, therefore carry great potential in biotechnology and medicine, as
exemplified by RNAi and CRISPR-Cas. My lab spent more than ten years dissecting the mechanisms of
CRISPR-Cas, and more recently has been developing genome editing applications based on our mechanistic
insights. (2) RNA can adopt defined tertiary structures to exert important functions. My lab has elucidated the
structure, function, and conformation dynamics of many riboswitches. The high-resolution information may
enable new antibiotics development. We now aim to combine genetic screen with biochemical purification to
systematically identify ligands for orphan riboswitches. Such studies often reveal novel aspects of bacterial
physiology, which may even be conserved in eukaryotes. We propose to work on the following four areas of
research: 1) Structure, mechanism, and genome editing applications of Type I CRISPR (CRISPR-Cas3); 2)
Mechanism of CRISPR immunity establishment by Cas1-Cas2 integrase; 3) Mechanism and genome editing
application of CRISPR-Tn7; 4) Dissecting riboswitch-controlled mechanism and bacterial physiology.

Public health relevance
The described structure-function studies of riboswitches in bacteria will contribute to the development of strategies to target these RNAs that control essential genes in human pathogens for antibiotics development. The described structure-function studies of CRISPR interference system in bacteria will contribute to the development of strategies to manipulate the CRISPR-Cas operon to control the proliferation and virulence of microbial pathogens. Novel genome editing applications will be derived from the proposed mechanistic studies.